Spectral X-ray Volumetric Imaging for Enhanced Cancerous and Healthy Tissue Differentiation in Breast Tumor Specimens

Abstract Clarix Imaging Corporation (Clarix) is focused on solving one of the largest problems in early stage breast cancer treatment, reoperations for positive margins. About 25% of the >200,000 patients who undergo lumpectomy in the US each year will face this additional procedure because current options for identifying positive margins intraoperatively are insufficient. Currently physicians rely on 2D specimen imaging for assessing margin status during surgery which cannot adequately represent the 3D margin morphology. Therefore, Clarix is developing a novel volumetric specimen imager, VSI, device that yields fully 3D images of the specimen with isotropic resolution which can significantly improve margin assessment and provide precise guidance for immediate re-excision before closing wound. We have previously demonstrated the ability of our VSI patented algorithms to overcome long scan times of conventional 3D imagers that would disrupt surgical workflow, and are now proposing development of a novel, algorithm-enabled spectral VSI system to further differentiate cancerous from healthy tissue. Recent developments by our founders allow for spectral CT with no special hardware. The addition of spectral imaging to our VSI system will enable automated cancer delineation in margin assessment improving surgical accuracy and pathologic assessment, and can also be applied to in vivo breast imaging. In the Phase I project we set out to demonstrate proof-of-concept of differentiation between breast tumors and healthy tissue using spectral image reconstruction tailored to VSI. The Specific Aims are to (1) create and validate simulated spectral VSI data of breast cancer specimens, (2) verify the robustness of the spectral VSI algorithm for breast cancer specimens, and (3) verify that spectral VSI can enable breast tumor delineation in patient specimens. Reaching the above Aims will firmly establish the feasibility of spectral CT for cancer differentiation further establishing Clarix VSI as the technical leader in the fast-growing specimen imaging market.

Public health relevance
Project Narrative Women who undergo lumpectomy for breast cancer have close to a 1 in 4 chance of needing a repeat operation because cancer was left in their breast. Providing surgeons with imaging tools in the operating room can increase rates of complete cancer removal in the first surgery. 2D mammograms of surgical specimens can already be taken in the operating room, but overlying tissue in a 2D image commonly masks the tumor. Clarix Imaging Corporation is developing 3D CT Volumetric Specimen Imager (VSI) to address these challenges providing surgeons with more actionable information. The focus of this project is to incorporate spectral imaging into the VSI to allow for increased differentiation between cancerous and healthy tissues.